Dysregulation of the unfolded protein response in the pathogenesis of non-alcoholic steatohepatitis

Project Summary/Abstract
Non-alcoholic steatohepa��s (NASH) disease will supplant hepa��s C as the leading indica�on for liver transplanta�on
this decade and has no FDA-approved therapy. To understand the root cause of NASH, we performed single-cell RNA
sequencing (scSeq) in a mouse model of NASH at �mepoints before and during disease progression. We ﬁnd that even
before NASH occurs, a protec�ve program called the unfolded protein response (UPR) is lost in HFD livers. Strikingly, this
UPR loss is most profound in the precise region of the liver where NASH is known to originate (“Zone 3”) in human livers.
We subsequently conﬁrmed that the UPR is also lost during human NASH. In this proposal, we seek to understand the
mechanism of UPR loss (Aim 1) in human NASH, and to more clearly delineate whether and how the Zone 3 UPR protects
against NASH (Aim 2). In Aim 1 we propose using precision cut liver slicing (PCLS), single-nuclei RNA sequencing, and
spa�al immunoﬂuorescence in human specimens to understand the rela�onship between lipid, oxida�ve stress, and the
UPR. In Aim 2, we propose rescuing the UPR and key signaling molecules in our mouse model of NASH (long-term) and in
human PCLS specimens (short-term) to understand how the UPR protects against NASH. These thema�cally related but
independent aims will help establish mechanisms of Zone 3 loss of the UPR, and how the UPR protects against NASH, in
turn clarifying the precise UPR targets that may be therapeu�cally tractable for trea�ng human NASH disease. This
proposal supports my long-term goal to understand how func�onal adapta�on across the liver Zones leads to a
vulnerability to speciﬁc liver diseases, of which the Zone-3 vulnerability of NASH is an exemplar. I have amassed
signiﬁcant exper�se in measuring Zone-speciﬁc gene expression using scSeq and immunoﬂuorescence coupled with
microscopy. This career development grant will enable me to expand this exper�se into speciﬁc tools which let me
interrogate func�on in speciﬁc liver zones. The goal and keystone of the career development por�on of this proposal is
to learn precision cut liver slicing and ex vivo culture, which would allow me to perturb zone-speciﬁc mechanisms
chemically and gene�cally in human liver �ssue. We have established a collabora�on with a leading liver PCLS expert
who has kindly invited me to train in his laboratory to learn this valuable method. In mice, I will learn how to use
adenoviral vectors (AAVs) as a zone-speciﬁc tool to study rescue of UPR genes lost in NASH. And ﬁnally, this award will
allow me solidify exper�se in scSeq analysis by learning advanced network analysis tools, which will in turn allow me to
analyze scSeq data in a zone-speciﬁc manner. The environment to conduct this research is superb. Dr. Goessling, the
primary mentor, is a renowned liver disease modeler, has exper�se in scSeq, and retains an excellent track record of
developing mentees into independently funded scien�sts. The broader Harvard and MGH communi�es oﬀer ample
opportunity for rich collabora�on, as evidenced by support of this applica�on from Dr. Omer Yilmaz at MIT, an expert in
modeling murine hypernutri�on, Dr. David Cohen at Brigham and Women’s, an expert in NASH and metabolism, and Dr.
Alex Shalek at MIT, an expert in scSeq, among others. My mentorship team and the broader ins�tu�onal environment
oﬀers ample resources and ins�tu�onal support to successfully carry out the proposed aims.

Public health relevance
Project Narra�ve Non-alcoholic faty liver disease (NAFLD) is a leading cause of liver disease in the United States, will replace hepa��s C as the most common reason individuals will need a liver transplant this decade, and has no FDA-approved treatment. This project will help us understand the root cause of NAFLD in humans by elucida�ng how a protec�ve gene�c program in liver called the unfolded protein response (UPR) is lost in pa�ents with NAFLD. Beter understanding of this protec�ve pathway may lead to a new family of drug targets for NAFLD which will help reduce the burden of this disease and prevent the need for liver transplanta�on due to NAFLD.